UK Spinal Cord & Brain Injury Research Center Core Grant

DESCRIPTION (provided by applicant): This application is in response to the NINDS Program Announcement requesting institutional center core grants to support neuroscience research. Accordingly, the current application seeks to create the UK Spinal Cord & Brain Injury Research Center (SCoBIRC) Core Grant to accelerate the research projects of 10 NINDS-funded investigators who are currently Pis on 12 NINDS R01s, and to enhance . The application asks for support for five core facilities: an Administrative and Bioinformatics Core, an Animal Surgery & TBI/SCI Model Core, a Behavioral Testing Core, a Microscopy, Image Analysis & Stereology Core and a Pharmacokinetics and Biomarker Core. Although some of the proposed technologies are currently in place in the laboratories of individual investigators, none of the cores currently exists. The proposal is for these resources to be centralized, in some cases upgraded and added to with additional equipment. Dedicated technical support is requested for each of the cores to insure that they will be run efficiently with minimal downtime and equipment failure, and serve to enhance the productivity of SCoBIRC and other NINDS-supported investigators. It is also expected that these cores will promote communication of data and foster overall collaboration. All of the participating investigators have documented needs for the use of most of the core facilities: 6 of 10 will use all 5 cores, 3 will use 4 of the cores and only 1 will use 3 of them. Use of the cores will be shared with other non-qualifying neurological investigators. The PI has had considerable administrative experience, and each of the Core Directors is fully qualified to direct the use of the proposed technologies. They will be backed up in 4 of the 5 cases with equally experienced Assistant Directors and dedicated technical staff who will perform pilot studies, train new investigators, handle scheduling, maintain supplies and equipment maintenance. The performance of the cores will be reviewed quarterly by a Steering Committee consisting of all of the qualifying investigators. It is anticipated that the existence of these cores will greatly enhance the accomplishment of the SCoBIRC mission which is directed at the discovery and clinical translation of therapeutic approaches for spinal cord and brain injury. In addition, these facilities will make available centralized technologies which will benefit UK neurological research in general, and improve the ability of both experienced and young investigators to compete for extramural funding.